Omic and Multidimensional Spatial Atlas of Metastatic Breast and Prostate Cancers

ABSTRACT - Administrative Core
The Administrative Core will serve as the organization, integration, and evaluation hub of the OMS Atlas. This
Core provides leadership, and supports and coordinates: (a) communications and integration within the OMS
Atlas and with the Human Tumor Atlas Network (HTAN); (b) proposal management, reporting, and compliance
activities; (c) oversight of budgetary and intellectual property issues; (d) unit milestone evaluation and
integration, and coordination with the SMMART Clinical Trial; (e) trans-HTAN projects; (f) organization of the
biomedical use case working group; (g) oversight of the OMS Atlas computational infrastructure and the Data
and Resource Sharing Plan; (h) data access and publication plans, including dispute resolution; and (i) HTAN
and External Advisory Committee (EAC) review. The Administrative Core will be led by Dr. Joe Gray (Contact
Program Director/PI, and Characterization Unit Lead); Dr. Gordon Mills (PD/PI, SMMART Clinical Trial
Director, and co-Lead Biospecimen Unit); Dr. Chris Corless (PD/PI and Lead Biospecimen Unit); Dr. Jeremy
Goecks (PD/PI and Lead of the Data Analysis Unit); and Center Administrator, Dr. Heidi Feiler. Drs. Annette
Kolodzie and Brett Johnson will manage integration of the SMMART clinical trial component, and biospecimen
and data sharing, respectively, across the units. This Core will coordinate OMS Atlas participation in the HTAN
programmatic meetings, such as HTAN Steering Committee meetings, annual Investigators meetings and site
visits. For planning and evaluation, it will organize OMS Atlas meetings, including monthly unit progress
meetings and Executive Committee meetings, and quarterly Steering Committee meetings, comprised of all
key personnel. Meetings will be video conferenced to facilitate participation and discussion. In addition, the
Administrative Core will oversee the Data and Resource Sharing Plan and development of the data networking
infrastructure platform in the Analysis Unit that will integrate with the HTAN-Data Coordinating Center (HTAN-
DCC) and the HTAN-Tissue Coordinating Center. The Administrative Core will coordinate publications of
analyses of the OMS data that reveal specific resistance mechanisms. It will oversee trans-HTAN project
development in collaboration with the OMS Atlas EAC and the HTAN. The Administrative Core will organize
annual EAC meetings to provide guidance on OMS Atlas activities. This review will be coordinated with an
annual retreat and HTAN site visit so the external advisors and HTAN leadership will have the opportunity to
interact with researchers from all OMS Atlas sites. To facilitate collaboration, PIs from other HTAN centers, the
HTAN-DCC and leaders of major cancer analysis generating programs (e.g., Cancer Systems Biology
Consortium (CSBC), LINCS, PS-ON, TCGA, ICGC, BD2K, and CTD2) will also be invited. In summary, the
Administrative Core will support and integrate activities between the Clinical Leads, Use Case Biology Leads,
and across the Biospecimen, Characterization and Data Analysis Units, which collectively form the OMS Atlas,
and coordinate these activities with tissue accrual and management through the SMMART Program.